Cardiovascular Surgery Research Training

Project Summary
The Cardiovascular Surgery Research Training Program’s main objective is to prepare full-time academic
cardiovascular surgeons, clinicians and scientists in cardiac and vascular basic and translational research. This
objective will be accomplished by an outstanding mentored research experience and rigorous programs of
didactic and career development training in a multidisciplinary setting. The overall goal is to train 4 postdoctoral
MD, PhD, and MD/PhD fellows per year in cardiovascular disease (CVD) research where trainees and faculty
will interact closely. This training Program is designed to train and prepare the trainees to conduct research using
state-of-the-art methods, conceptualize research problems, and publish research findings for successful
academic careers as independent investigators. The fundamental need for research training in cardiovascular
surgery is highlighted by studies showing that the number of clinician/surgeons and PhD scientists in translational
CVD research continues to decline. Furthermore, research findings demonstrate that clinician-scientists who are
most successful to date are the ones who have undergone a period of intense research training for two or more
years as an integral part of their training. One- to two-year training of PhD scientists during their early
postdoctoral training period will certainly help build a solid knowledge- and experience-based foundation to
become excellent cardiovascular researchers in the coming days. Upon completion of this training program the
cardiac and vascular surgeons and the cardiologists will be able to better integrate into the rapidly expanding
and changing fields of specialized cardiovascular medicine and surgery. In parallel, in addition to having state-
of-the-art cardiovascular research experience, the postdoctoral PhD scientists will be well-trained to address the
major cardiovascular health issues, research questions and challenges of the day. While there are a few good
training programs in cardiac medicine and surgical research, they tend to be limited in focus to certain specific
issues such as transplantation, ventricular mechanics, and gene and cell-based therapies. The proposed training
Program has been built upon an integrated approach to the training of a new generation academic cardiovascular
surgeons and scientists, which in turn will result in excellent quality of teaching, success of research funding,
and publication of high quality basic and translational research findings in the field of cardiovascular research.

Public health relevance
Project Narrative Cardiovascular diseases are the major causes of morbidity and mortality in the United States. This Cardiovascular Surgery Research Training Program aims to prepare next-generation scientists and clinician- scientists in state-of-the-art cardiovascular research by training surgery residents and postdoctoral fellows through outstanding mentored research experiences. This Program will help advance basic and translational research to develop novel therapeutic modalities by a group of well-trained cardiovascular academic researchers.